Exploiting metabolic toxicities to identify compounds that inhibit cholesterol metabolism in M. Tuberculosis

? DESCRIPTION (provided by applicant): Tuberculosis (TB) is a lasting global epidemic that claims ~1.5 million human lives annually. Mycobacterium tuberculosis (Mtb) is the causative agent of TB and this bacterium establishes long term infections by surviving within macrophages and manipulating the host immune response. Within lung tissue Mtb can persist for decades sequestered away from the pressures of the host immune response. During this persistent infection Mtb solely utilizes host-derived nutrients for survival. Mtb has the ability t utilize host-derived cholesterol during an infection to supply energy producing and/or biosynthetic pathways. Therefore, inhibition of cholesterol catabolism may be a weakness that can be exploited for discovery of new anti-Mtb drugs. For this project we will develop a cell-based assay suitable for HTS that can identify inhibitors of cholesterol catabolism in Mtb. Aim 1: we will develop a robust chemical-suppressor HTS assay 384-well format using the Mtb Icl1 strain. Aim 2: we will complete a pilot HTS and validate hits from the screen. Aim 3: will focus on identifying the enzyme targets of the HTS hits. These studies will yield a HTS ready assay and provide proof of principle that our approach can identify selective inhibitors of cholesterol catabolism in Mtb.

Public health relevance
PUBLIC HEALTH RELEVANCE: Mycobacterium tuberculosis (Mtb) is the causative agent of Tuberculosis and is responsible for approximately 1.5 million deaths annually. A key component of this disease is the ability of the bacterium to persist for long periods in the human host. The proposed research will develop an assay suitable for HTS to identify inhibitors of Mtb cholesterol catabolism. This assay will allow us to identify new tools to better understand cholesterol catabolism in Mtb and will potentially identify new anti-TB drugs.